Administrative Core

Administration and Coordination Core
Project Summary
The administrative and coordination core of the proposed U54 Center for Spatiotemporal Tumor Analytics for
Guiding Sequential Targeted Inhibitor : Immunotherapy Combinations (ST-Analytics is designed to
promote and support the integrated research efforts of scientists from the ISB, Yale, and UCLA, as well as our
Outreach program, our Pilot Projects and Cross-Consortium Projects. The scientific programs of ST-Analytics
are designed to resolve how to best harness immunotherapy/targeted therapy sequential combinations for the
treatment of solid tumors in the clinic, starting with a focus on metastatic cutaneous melanoma. This requires
bringing together a cross-disciplinary mix of clinical, biological, physical, engineering, and computational
scientists, as well as state-of-the-art, multiomic profiling tools, syngeneic mouse models, and a rich bio-repository
of highly relevant patient tissues. Meeting the ST-Analytics scientific goals requires a responsive administrative
structure that (i) promotes and enables effective communication and resource sharing between the ST-Analytics
researchers and the broader Cancer Systems Biology Consortium (CSBC), (ii) establishes a highly interactive
environment wherein ST-Analytics researchers can be good students and teachers of each other, (iii) promotes
achieving the program specific aims in a timely manner, (iv) intervenes as early as possible when scientific and
logistic conflicts arise, (v) promotes diversity in our scientific workforce through various mechanisms, including
but not limited to seed project funding, outreach programs, and raising awareness of these critical issues during
our remote and in-person meetings, and (vi) monitoring the scientific integrity and robustness of scientific
designs. The ST-Analytics administrative CORE should facilitate the free flow of data, new ideas, experimental
protocols, customized reagents, and biospecimens between the institutions. It should establish working
relationships with other funded centers. It should facilitate clinical or commercial translation and educational
outreach. It should encourage flexible thinking in anticipation of new opportunities or unexpected roadblocks.
Finally, it should facilitate a healthy environment of self-evaluation.